Analysis of RNAs targeted to the long-distance projections of ventral hippocampus

PROJECT SUMMARY
In this R21 exploratory/developmental grant application, we propose to develop and validate
methodologies for in vivo analysis of RNA targeting in specific circuits, as well as investigating the regulation of
these RNAs during long-term memory storage (LTM). The significance of RNAs localized to dendrites for local
translation is well known. However, current methodologies do not provide accurate identification of RNAs
targeted to distinct subcellular compartments. For example, several studies utilizing molecular analysis of
microdissected dendrites or neuronal processes have identified RNAs in the distally localized neurons of diverse
organisms, including sea slugs and mice. A major caveat of this approach is that the microdissected regions
contain dendrites/neuronal processes from several different neurons as well as segments of interneurons and
localized non-neuronal cells. Thus, this approach yields RNAs from dendrites of multiple neurons and non-
neuronal cells, preventing our ability to identify the neuron-specific, distally targeted RNAs necessary to generate
a more profound understanding of RNA localization and LTM. Since, learning and memory involves changes
that are circuit-specific, the lack of robust and reliable methodologies to identify circuit-specific, targeted RNAs
acts as a critical barrier to our understanding of RNA targeting in vivo, as well as the role that these RNAs play
in both in LTM and disorders of memory. To address this critical knowledge gap, we here propose a strategy
that starts with the expression of a tagged kinesin that mediates the transport of RNAs in specific neurons
followed by immunoprecipitation of kinesin complexes from distinct neuronal projections and identification and
rigorous characterization of associated RNAs. We anticipate that our kinesin-based strategy will yield deep
insights into in vivo RNA targeting and their modulation by LTM.

Public health relevance
PROJECT NARRATIVE Though, several studies including our own have demonstrated that RNAs are targeted to synapses and that these RNAs play a critical role in memory storage, we do not know much about RNAs localized to specific synapses in vivo. In this proposal, by characterizing RNAs associated with a GFP tagged molecular motor protein KIF5C, we will isolate and characterize KIF5C targeted RNAs in ventral hippocampus-medial prefrontal cortical and ventral hippocampus-basolateral amygdala synapses. Successful completion of these studies will assess whether populations of RNAs become selectively enriched in specific synapses in vivo and their significance in the consolidation of contextual fear memory.